Feasibility of a Multi-Phase Algorithmic Non-Thermal Ablation Technology for the Treatment of Inoperable Tumors

Project Summary / Abstract
An estimated 34,000 patients are diagnosed in the US with primary liver each year with a substantially larger
number of patients will developing liver metastasis from a broad range of primary tumor sites. Unfortunately, the
vast majority of these patients are not candidates for surgical resection, which is the only reliably curative
treatment for liver tumors, yielding a five year survival rate of approximately between 10 and 20% for patients
with primary disease. The primary clinical challenge is that most tumors form deep within organs, near major
blood vessels, bile ducts, or nerves which complicate surgical removal and contraindicate other first line
treatments. Phased Algorithmically Controlled Electrotherapy (PACE) is a new minimally invasive technique
developed by the Gradient Medical for the treatment of inoperable tumors which uses ultrashort high intensity
electrical pulses to destabilize the cell membrane and induce a tunable combination of necrotic and apoptotic
cell death. In this proposal we investigate the feasibility of this approach for the treatment of liver tumors through
two specific aims: 1) Characterization of Selective Targeting with ACE protocols. 2) Development of a Multiphase
Alternating Polarity Pulse Generation System. In the proposed study Gradient Medical will design and build a
novel pulse generation system which enables instantaneous electrical energy delivery between up to four
synchronized temperature sensing applicators. Feasibility of this approach will be demonstrated using a
benchtop perfused liver model which enables direct visualization of the treatment zones created by the non-
thermal pulsed electric field mediated cell death mechanisms. Preliminary safety and in vivo efficacy will be
evaluated in an in vivo large animal liver model. The results from this feasibility study will be used to generate
preliminary treatment planning algorithms necessary for subsequent Phase II in vivo safety and efficacy studies
against spontaneous liver tumors in veterinary patients.

Public health relevance
Relevance to Public Health The vast majority of patients diagnosed with liver cancer will not be candidates for surgical treatment. Unfortunately, these patients tend to have poor responses to standard treatments including radiation and chemotherapy resulting in a five-year survival rate of approximately 20%. This study will investigate the feasibility of PACE, a minimally invasive cancer therapy which uses ultrashort alternating polarity pulsed electric fields to rapidly destroy deep seated inoperable tumors through non-thermal mechanisms.